Diabetes Research Training Program

PROJECT SUMMARY / ABSTRACT
There is an ongoing and urgent need to devise better approaches to prevent, treat, and ultimately reverse
diabetes, which requires constant training of highly qualified cohorts of investigators. The Diabetes Research
Training Program at the University of Iowa is mentoring and launching the next generation of investigators who
will address this critical need by focusing their scientific efforts on diabetes. We seek, in this competing
renewal, ongoing support for 6 postdoctoral positions. Both physician and PhD scientists will be trained and
most will be appointed to the program for 2 years. There are no other diabetes research training opportunities
in the state. The program is built on the exceptional strength and depth of the University of Iowa Fraternal
Order of Eagles Diabetes Research Center (FOEDRC), which is driving innovative strategies aimed at further
understanding the pathophysiology of diabetes and its complications and at devising novel preventative and
curative strategies. Training in basic and clinical scientific investigation will be augmented by a core curriculum
in diabetes, metabolism, grant writing, and research ethics. Trainees involved in clinical and/or translational
diabetes research will enroll and complete a Master of Science in Translational Biomedicine. All trainees will
receive tailored career mentoring to ensure a successful transition to their next career stage. Training will be
underpinned by synergistic scientific collaborations across multiple disciplines of relevance to diabetes
research, as embodied by the Center. Mentored research opportunities available in the Program span basic
and mechanistic investigation across a broad range of model organisms to translational and epidemiologic
studies in humans. Program mentors comprise 44 diverse and interactive faculty with vigorous diabetes
research programs, stable extramural funding, and robust training records. They span 5 colleges, 12
departments and 8 clinical divisions. Training will leverage existing synergies between collaborating
investigative teams. Recruitment of outstanding trainees will be secured by the broad reach of the FOEDRC.
Qualified physician scientist trainees will be recruited from the Physician Scientist Training Pathway and from
clinical fellowship training programs in Internal Medicine, Obstetrics and Gynecology, and Pediatrics. PhD
scientist trainees will be selected from national pools recruited into Program mentors’ labs. The training
program will be administered through the FOEDRC, and will be overseen by an executive committee
comprising 2 (multi) principal investigators and 5 co-directors, all of whom are seasoned investigators with
uncompromising commitment to mentoring trainees.

Public health relevance
PROJECT NARRATIVE Current diabetes treatments are woefully inadequate, and diabetes remains a leading cause of disability and death among Americans. Our program will meet a growing need within our region and the country for a cohort of capable diabetes investigators, by training new scientists in cutting edge research aimed at better treating and preventing diabetes. The trainees in this program will be scientists who are not yet independent but have earned their PhD and/or MD and intend to head their own diabetes research laboratories.